CLINICAL ELECTROPHYSIOLOGY OF THE VISUAL SYSTEM

The visual function of both patients with ocular diseases or lesions in the visual pathways and normal subjects is measured objectively with electrophysiological techniques. The data are correlated with those obtained with psychophysical tests of visual function. The results obtained contribute to the diagnosis of ocular and neural disorders that affect vision and are needed to characterize their nature and evolution. They are also valuable in the assessment of the effect of different forms of treatment on the outcome of these diseases.